6 - Market Learning and Healthcare Disparities

PROJECT SUMMARY/ABSTRACT
Project 6 – Market Learning and Health Care Disparities
Health care outcomes depend crucially on whether patients are able to access providers with high clinical
quality. This project studies the role of market learning in health care – the process by which markets, driven
by patients and their decision-making partners like ambulance drivers and referring physicians, allocate
patients to providers. When market learning favors high-quality health care providers, patients experience
better health outcomes, and, moreover, providers are incentivized to improve quality because their patient
volumes depend on it. An implication is that socioeconomic disparities in market learning can lead to disparities
in treatment quality and thus health outcomes.
The conventional wisdom is that patients and their surrogates are poorly informed about quality variations,
limiting the scope for market learning. Our preliminary work suggests, however, that market learning operates:
high-quality hospitals tend to be larger and are more likely to grow than their low-quality peers. This work
expands on the preliminary exercises in several ways to paint a nuanced picture of where (and for whom)
health care markets raise clinical quality.
This project takes two approaches to analyze health care markets: the first assesses hospitals' market share at
a point in time and over time, and how that share correlates with a broad set of quality metrics; the second
builds econometric models of the hospital choice of the patient to estimate how much value patients place on
hospital quality. Quality includes clinical outcomes, clinical processes, and patient satisfaction. The project's
first Specific Aim investigates the role of patient attributes like socioeconomic group and insurance in enabling
patients to reach high quality hospitals. It focuses in particular on vulnerable populations, like those with
chronic illness or those from areas with poor population health. This Aim will show how health care markets
function for socioeconomic groups and how markets affect health care disparities. The second Aim expands
the scope of the market analysis to cancer patients. Health care markets can potentially function better for
cancer than emergency conditions because cancer patients have more time to decide on a provider, widening
their scope for choice. This Aim will provide the first estimates of how markets function for cancer and how they
compare to markets for acute conditions. The project's third Aim considers technology as an additional factor
that determines market allocation. It will estimate the extent to which markets favor technology above and
beyond quality, how patients trade off between technology and quality, and how patients' preferences for
technology affect clinical outcomes. Finally, we synthesize the findings of these analyses together with those of
other Projects within the program project to assess the role of markets in relation to other tools in driving the
value and quality of care delivery to improve the health of an aging population.

Public health relevance
PROJECT NARRATIVE – PUBLIC HEALTH RELEVANCE A key element of public health is ensuring that patients who fall ill receive high quality health care. This project assesses how health care markets direct patients to health care providers and how markets influence the clinical quality and outcomes that patients experience. It also studies the effect of market learning on health care disparities across socioeconomic groups and vulnerable populations in particular.